CISAPRIDE IN TREATMENT OF CHILDLREN WITH GI MOTILITY DISORDERS

To study gastrointestinal motility as measured by esophageal manometry and gastric emptying in infants, children and adults with motility disorders before and after Cisapride treatment.